CAREGIVER DEFINITION EFFECTS--SOCIODEMOGRAPHICS &HEALTH

DESCRIPTION (adapted from investigator's abstract): An informal caregiver is a person who provides unpaid assistance or supervision to someone whose cognitive, physical, or psychological health prevents his or her from living independently. Caregiver is defined differently across studies, from anyone who helps the care recipient with 1+ personal or instrumental activity of daily living to the spouse of the care recipient. Thus, some definitions misclassify caregivers as non-caregivers and vice versa. To date, no study has evaluated how the definition of caregiver affects the composition of caregivers in a sample or biases the estimate of the association between caregiving and health outcomes. Such results would improve estimates of the association of this association and identify definitions that misclassify minorities, older women or other subgroups as non-caregivers. The proposed study will use the AHEAD data set to test two hypotheses: 1) The definition of caregiver affects the sample composition: more minority, older women, and non-coresident caregivers are in samples that use a broad definition (e.g. help with 1+ ADL/IADLs) compare to a narrow definition (e.g. help with 2+ADLs); and 2) Compared to a narrow definition of caregiver, broad definitions will underestimate associations between health status of elderly respondents and receipt of caregiving. The AHEAD study is ideally suited for these analyses. The impact of different definitions of caregiver on caregiver characteristics (e.g. sex, gender, race/ethnicity, etc) and characteristics of care recipients will be assessed thorough univariate and multiple logistic regression analyses. The results of this study will lay the groundwork for an RO1 application to evaluate the effects of caregiver definition on health decline and health services use in a prospective study of caregivers versus non-caregivers.